Atypical B Cells: Origin and Autoreactivity

PROJECT SUMMARY (ABSTRACT)
Humoral immunity forms the basis for vaccine-induced immune protection. Following infection and vaccination,
a fraction of activated B cells differentiates into long-lived plasma cells (LLPCs) or memory B cells to provide
longitudinal protection against pathogens. Whereas LLPCs constitutively produce circulating antibodies,
memory B cells in circulation and tissues are reactivated following antigenic reencounter through rapid
expansion and antibody production. Existing forms of vaccination rely upon generation of neutralizing
antibodies by LLPCs. However, evolving pathogens harboring frequent mutations at sites of immune
recognition might be better targeted by heterogeneous memory B cells, with their broader distribution across
tissues and enhanced cross-reactivity. Understanding these aspects of memory B cells is thus crucial for
leveraging the additional layer of protection offered by the heterogeneous population in vaccine development.
Co-expression of Tbet and CD11c (Tbet+CD11c+) marks a subset of such heterogeneous, antigen-experienced
B cells that arises in aging, infection, and autoimmunity, respectively, termed age-associated, atypical, and
double-negative (in humans, IgD- CD27-) B cells which mediate protection from pathogens in mice and
humans. Their contribution towards protection is likely in part due to their unique localization as a resident
memory B cell subset in tissue, most notably the splenic marginal zone which via its exposure to circulation
provides front-line defense against bloodborne pathogens upon rechallenge. Tbet+CD11c+ B cells also infiltrate
non-lymphoid tissues, including the liver, with residency establishment at non-lymphoid tissue sites positioning
them for early detection of invading pathogens. Confounding their investigation, however, is lack of knowledge
of the relationship between the non-lymphoid and lymphoid populations. Tbet+CD11c+ memory B cells also
contain autoreactive clones and appears to be a major source of autoantibodies, which may be pathogenic.
Although the ability of Tbet+CD11c+ B cells to mount robust antibody responses at tissue sites of infection
makes them an attractive candidate to target in vaccination, we need to understand the relationship between
the lymphoid and non-lymphoid pools, and how the balance between their protective and autoreactive
functions is regulated. Are these cellular sites, and protective and autoreactive functions, a consequence of
two pools of Tbet+CD11c+ B cells? Do cross-reactive Tbet+CD11c+ B cells, recognizing both self and non-self,
rely on environmental signals to mediate protection or pathology? To address these knowledge gaps, in this
revised application, we will identify the mechanism by which Tbet+CD11c+ B cells infiltrate non-lymphoid organs
and determine if they maintained therein and elucidate the nature of their autoreactivity. Both goals fit the R21
Exploratory/ Developmental Grant mechanism. We are at “early and conceptual stage(s) . . . of the
development of novel applications that could have a major impact” on our understanding or tissue protection
provided by heterogeneous B cells and how they may be safely targeted for vaccine development.

Public health relevance
PROJECT NARRATIVE Antibodies produced following vaccination form the basis for protection against viruses and other microbes. B lymphocytes produce protective antibodies after vaccination. Our goal is to analyze a relatively understudied population of B cells following viral infection in mice, to determine how these cells develop in different organs in the body and how they contribute to protection against infection.